A nanoengineering platform for programmable gene editing therapies against rare diseases

PROJECT SUMMARY
More than 300 million people worldwide are affected by a genetic health condition. Over 4,400 genetic
diseases have been identified; nearly all of which are considered rare, which limits the amount of research
each receives. Gene therapy is an attractive approach for treatment of genetic disease because of its
versatility and broad applicability. Genome editing systems such as CRISPR-Cas9, base editing and prime
editing have revolutionized gene therapy research and other fields of life science, however, few gene editing
treatments have reached the market and clinical translation still faces important challenges. Among them is the
need for safe and effective gene therapy delivery vehicles and platforms for their creation.
In this project, we will design and test a new class of programmable, non-viral gene therapy carriers and cargo
– virus-inspired DNA origami (VIDO) vectors and repair templates – and Essemblix GT, a nanoengineering
platform tailored for their production. In contrast to other gene therapy delivery vehicles, VIDO products are
modular and easily modified for different diseases. Moreover, they are structurally well-defined with little
intermolecular variability, facilitating regulatory approval and clinical translation. To our knowledge, this will be
the first project to investigate the use of DNA origami for encapsulation and delivery of gene editing agents.
In Aim 1, we will demonstrate that CRISPR-Cas9 knock-in efficiency is improved by folding and compacting
homology-directed repair (HDR) templates with DNA origami methods. VIDO-folded reporter templates will be
compared against unstructured controls when delivered via electroporation to HEK293T and Jurkat human cell
lines at two different genome insertion sites. Nuclear entry will be determined by confocal microscopy of
fluorophore-labeled template and knock-in efficiency will be assessed by flow cytometry.
In Aim 2, using the same cell lines and genomic targets, we will demonstrate VIDO vectors can encapsulate
and co-deliver CRISPR-Cas9 editing agents and VIDO templates, are readily taken up by cells and induce
knock-in efficiency that is competitive with delivery of the same agents via virus-like particles (VLP).
Endosomal escape and gene expression will be tracked via confocal microscopy and flow cytometry. In both
aims, correct genomic integration will be confirmed via Illumina sequencing.
Successful completion of these aims will establish VIDO vectors and templates as new, programmable gene
therapy products with key advantages over existing alternatives. By making it practical to rapidly design and
create such VIDO products, the Essemblix GT nanoengineering platform could shift gene therapy research
toward a paradigm of gene therapy engineering, thus enabling researchers to deliver more treatments for rare
diseases to more patients more quickly.

Public health relevance
PROJECT NARRATIVE Gene therapies have the potential to treat the millions of people suffering with a genetic health condition by correcting the underlying genetic problem. Better, more modular and easily programmable molecular vehicles for carrying and delivering genetic repair machinery would help researchers develop such treatments faster and more affordably. In this project, we will develop and test a new class of such programmable carriers for gene therapy treatments and a nanoengineering platform for rapidly and reliably producing them.